NEUROSECRETION OF GROWTH HORMONE IN CHILDREN WITH POOR GROWTH

Overnight 12 hr secretory growth hormone studies(ICGH)(q 20 minutes) are compared to provocative GH studies(PGH) peak GH release in children with slow growth velocity. Subjects are divided into four categories: normal (N)/N; N/low; low/N and low/low with respect to PGH/ICGH respectively. Response to GH treatment is compared by category in those children who are entered into GH treatment programs.